Advanced Imaging and Computational Approaches

The Advanced Microscopy and Computational Approaches Core (Core C) will provide advanced
imaging and computational approaches to support this Program Project in elucidating the
molecular mechanisms of DNA replication stress that drive therapeutic response and resistance
in SCLC. The microscopy approaches provided include multi-color STORM imaging, live-cell
single-molecule tracking, and time-lapse microscopy of cells and tumoroids using established
protocols and methods. Core C will establish automated data analysis pipelines for quantitative
analysis of microscopy, sequencing and mass spectrometry data generated by all the Projects,
and provide strategies for integration of the different data modalities. Core C will establish an
infrastructure for dissemination of data, results, and pipelines, and provide interactive
web-based user interfaces to allow the scientific community to easily explore the data generated
in the projects. Core C will also develop teaching material covering the microscopy and
computational approaches implemented.

Public health relevance
The combination of modern microscopic and advanced computational methods can provide detailed insight into how DNA is repaired after damage. These insights can reveal vulnerabilities specific to cancer cells that can be used to develop more effective treatments.